The role of N6-methyladenosine RNA modification in programmed and aberrant DNA mutagenesis in B cells

PROJECT SUMMARY
Background: VDJ recombination, Class switch recombination (CSR) and somatic hypermutation (SHM) are
three B lymphocyte specific processes that mediate antibody gene diversification. VDJ recombination requires
the DNA double strand generation by the Recombination activation genes (RAG1 and RAG2) whereas CSR and
SHM requires the single-strand DNA break activity of the Activation Induced Deaminase (AID) enzyme. Both
RAG1/2 and AID activities are coupled with noncoding RNA transcription at sites of DNA break/mutation. The
properties of the ncRNAs generated at sites of programmed DNA breaks are poorly characterized in B cells.
Recently, advances in biology have provided compelling evidence that post-transcriptional and co-transcriptional
modification of ncRNAs determine a component of RNA epigenomics and have significant role in driving cellular
development and function. In this application, supported by published study (Nair et al,2021; PMID: preliminary
data generated in our laboratory, we are evaluating the role of RNA modification N6-methyladenosine (m6A) and
its associated enzymes METTL3 and METTL14 in B cell development, function and genomic integrity.
Objective/Hypothesis: In his proposal, we will determine how RNA methylation m6A on transcripts generated
in the IgH locus and the rest of the B cell genome controls programmed DNA recombination, antibody gene
diversification and prevents chromosomal instability.
Specific aims: Aim 1: Does m6A reader protein YTHDC1 drive CSR and SHM? Aim 2: What is the
mechanism of function of m6A modification and YTHDC1 in promoting IgH diversity and preventing genomic
instability in B cells?
Study Design: Using cell lines and mouse models, we will establish that along with m6A writers (shown
previously), the m6A reader YTHDC1 protein is important for class switch recombination and somatic
hypermutation. Thereafter, using a combination of genome and RNA editing toolbox generated with
CRISPR/Cas9 technology, we will evaluate the effect of RNA methylation and YTHDC1 protein to induce CSR.
A RNA recognition motif of YTHDC, which is necessary for efficient CSR, will be evaluated for properties that
drive CSR. Whether YTHDC1 promotes RNA dependent granule formation for promoting CSR (or SHM) will be
evaluated using STORM microscopy. A cell-based assay system to evaluate SHM has been developed, the
role of YTHDC1 and other m6A related proteins will be evaluated for SHM efficiency.
Disease Relevance: B cells are a central component of the adaptive immune response, but also prone to
undergo leukemias and lymphomas when antibody gene diversification processes are not well controlled.
Proposed studies leads to a better understanding of the mechanism of antibody gene diversification but also
educate us how B cell cancer (specially in context of DLBCL and Multiple Myeloma) are prevented.

Public health relevance
PROJECT NARRATIVE During B cell development rapid transcription of B cell lineage specific genes and the immunoglobulin loci coding and noncoding segments are essential for generation of antibodies that are specific for neutralization of many antigens we encounter. The transcriptional and post transcriptional regulation of the noncoding RNAs generated during B cell development is important since these ncRNAs not only play an important role in controlling gene expression, genome organization and DNA rearrangement mechanisms, but when not controlled properly cause genomic instability. In this application, we evaluate the role of N6-methyladenosine (m6A) modification of various ncRNAs and reader protein YTHDC1 expressed in the B cell genome in promoting antibody gene diversification and conserving B cell genomic integrity.